Development of a GBP-based glycosylation analysis system

Project Summary / Abstract
The surface of cells and proteins are decorated with complex polysaccharide modifications (glycans) which help
shape identity, function, and immunogenicity. Glycans have been shown to play major roles in diseases such as
cancer and in the function and stability of therapeutic proteins. Research on glycan structures is challenging and
expensive, requiring specialized equipment and large amounts of samples to obtain functional structural isomeric
information. Using glycan binding proteins to assay glycan structure is a rapid and affordable option for glycan
isomeric structural analysis but there is no software capable of providing automated analysis of the data. To
meet this need, two groups with a history of implementing transformative glycan assay and software solutions
will improve upon glycan binding assays offered by Z Biotech LLC and optimize the glycan structure analysis
with a prototype software developed by the Haab laboratory. Preliminary analysis with the software has already
demonstrated remarkable ability to predict glycan structural features from purified glycoproteins and biological
samples but has revealed limitations that this work will address. In the Phase I of this SBIR project, we will
address these limitations in three aims: 1) We will supplement and improve the available data used for predicting
binding by collecting a large glycan array dataset with a wide dynamic range for accurate estimates of binding
affinity; 2) We will expand our coverage of glycan epitopes by supplementing with additional lectins and
antibodies; 3) We will optimize the algorithm for different glycan binding assays by using control glycans to
account for phase shifts in affinity specific to the platform. This work will transform glycan structure analysis by
offering a new low-cost glycan isomeric structure analysis platform which will open up new opportunities for
clinical and pharmaceutical research.

Public health relevance
Project Narrative Glycan binding protein assays offer unique value in glycan structure analysis by providing cost-effective and rapid insight into functionally distinct structural isomers but are limited by the difficulty of interpretation. The goal of this SBIR project is to improve the glycan binding assay and prototype software to provide a glycan binding platform with automated glycan structure analysis. This work will transform the use of glycan binding proteins and open up new opportunities for studying glycan structures.